Prediction Tools for Diabetic Retinopathy Among Veterans Using Machine Learning and Large-scale Data Analysis Techniques

Diabetic retinopathy is a form of microvascular end-organ damage that can result in vision loss and is an
outcome that Veterans suffer at a higher rate than the general population living with diabetes. Current
retinopathy screening programs lack precision which can mean that high-risk patients struggle to get the care
they need when they need it. Access to screening is limited by a mismatch of demand and supply of available
eye care providers or teleretina screening opportunities. There is currently very little individualization in diabetic
retinopathy screening and management strategies. Therefore, precision medicine approaches which attempt to
match optimal screening strategy to the risk factors of an individual patient would be ideal to address the
unmet need for patient-centered diabetic retinopathy screening and care. The overall goal of this career
development award (CDA) is to develop sophisticated bioinformatics and machine learning tools to identify
Veterans at high risk for retinopathy progression while at the same time developing Dr Christopher’s expertise
in advanced statistical and machine learning strategies. Doing so will support her career goal of enhancing
ophthalmic outcomes for Veterans, specifically targeting diabetic retinopathy. This proposal will leverage a
major asset of the VA healthcare system, the electronic medical record, with clinical and administrative
information available as the largest integrated healthcare system in the country. In Aim 1, we will develop and
validate a phenotype for identifying patients with diabetic retinopathy from electronic health record data. In Aim
2, we will apply machine learning techniques for retinal image analysis to generate prediction tools for future
diabetic retinopathy at the time of a negative retinal photography screening. Finally, Aim 3 will describe the
phenomenon of early worsening of retinopathy following rapid improvement in glycemic control. This has not
previously been described in large cohorts of patients, and we will explore predictors including the relative
importance of medication type and HgA1c. This proposal is innovative in its leveraging of the existing VA
diabetic teleretina screening program to generate a very large repository of retinal photographs for study, its
focus on risk factors and machine learning strategies to predict future retinopathy, and development of tools
which will lead to personalization of retinopathy screening protocols at the individual Veteran level. The career
development plan is strategically designed to achieve these aims via the proposed didactic, technical, and
career development objectives. Specifically, advanced statistical training, Big Data infrastructure within
healthcare, and machine learning and artificial intelligence for predictive analyses educational goals will be
realized with a combination of coursework, training, and mentorship. The assembled team of mentors, each
outstanding investigators in their own fields, will provide content, methodologic, and career development
guidance to fill gaps in the applicant’s training and ensure progress towards independence as a clinician-
investigator. Upon successful completion of the proposed scientific and training aims, the applicant will be
well-equipped to utilize large-scale data analysis techniques and machine learning to improve ophthalmic care
for Veterans for years to come.

Public health relevance
Due to the high prevalence of type 2 diabetes and comorbid conditions in the Veteran population, diabetic retinopathy is a significant concern leading to vision loss and placing a considerable burden of screening and treatment on the VA healthcare system. This research project aims to develop personalized risk profiles for diabetic retinopathy in Veterans by utilizing artificial intelligence and longitudinal analysis of electronic medical record data and retinal imaging to predict future diabetic retinopathy development. Ultimately, the study's insights can contribute to improving eye care outcomes for Veterans with diabetes, guiding screening and early treatment strategies, and reducing the burden of diabetic retinopathy within the VA healthcare system.